Identification of longevity targets in C. elegans protein translation mutants

DESCRIPTION (provided by applicant): The research proposed in this fellowship application addresses an extremely interesting question in the field of aging and mRNA translation: How come many organisms, including the nematode C. elegans defective in key components of the mRNA translational machinery are long-lived and stress resistant? Interestingly, in response to environmental stress, all eukaryotic cells shut down their biosynthetic activity and mount an integrated stress response. During recovery, certain proteins are produced against the backdrop of general translational repression. The main objective of the present application is to uncover the biochemical mechanisms that enable the escape of stress-induced mRNAs from translational repression during the stress response and the actively translated mRNAs involved in the longevity phenotype. The project will examine the hypothesis that key translational regulatory factors belonging to either S6 kinase (S6K) and/or the group of eukaryotic translation initiation factors (eIFs) can specifically mediate this escape. The focus will be on rsks-1/ S6K, as well as on ife-2/eIF4E, one of five isoforms in worms that is an mRNA 5'-cap binding protein. Both S6K and eIF4E may be at the heart of regulating a pathway that mediates stress-specific and longevity translation. The main question to be addressed is: What are S6K and eIF4E downstream translational targets that need to be synthesized in order to allow survival under stress and aging? This question will be addressed with a series of cutting-edge ribonomic and proteomic approaches using the nematode, C. elegans as an experimental system. The model organism is extremely useful for aging research because of its rapid development, short lifespan, and the ability to knock-out genes through RNAi with great ease. PUBLIC HEALTH RELEVANCE: Population aging is progressing rapidly and is having a profound global demographic trend in the twenty-first century. However, this progression is poorly understood at both the cellular and molecular level. This proposal aims to determine how mRNA translation, which is a tightly regulated cellular process that affects an organism during growth, reproduction, as well as survival in response to nutrient availability and energy levels, modulates organismal aging and stress resistance. As an age-related decline in protein synthesis rate is observed in many organisms, this research might have direct relevance for understanding the role of protein synthesis in human aging.

Public health relevance
Population aging is progressing rapidly and is having a profound global demographic trend in the twenty-first century. However, this progression is poorly understood at both the cellular and molecular level. This proposal aims to determine how mRNA translation, which is a tightly regulated cellular process that affects an organism during growth, reproduction, as well as survival in response to nutrient availability and energy levels, modulates organismal aging and stress resistance. As an age-related decline in protein synthesis rate is observed in many organisms, this research might have direct relevance for understanding the role of protein synthesis in human aging.